Biospecimen Procurement and Translational Pathology Shared Resource Facility

PROJECT SUMMARY/ABSTRACT
The Biospecimen Procurement and Translational Pathology Shared Resource Facility (BPTP SRF) is a
Markey Cancer Center (MCC)-managed resource. It facilitates the use of well-annotated human and animal
specimens and provides a wide range of translational pathology technical services in support of MCC clinical,
translational, population-based and basic science research. Over the award period, the BPTP SRF has
increased annual biospecimen dispensation from 1,738 in FY12 to 4,446 in FY17 (156% increase), increased
the total number of MCC users by 23% (48 in FY17, up from 39 in FY12) including 38 peer-reviewed funded
MCC users in FY17 (49% of all BPTP users) and expanded its range of services. New services include:
targeted and time sensitive collections, such as intra-operative, rapid fresh tissue collections supporting work in
cancer metabolism; the development of novel model systems (e.g., Warburg tissue slices for metabolic
analysis, patient-derived xenograft, organoids); review of all clinical trials, including investigator-initiated trials,
to identify specimen collection needs and develop collection protocols; fresh tissue collections and rapid blood
processing for clinical trials, resulting in support for 40 clinical trials over the funding period. The addition of a
research histology laboratory, operated per clinical guidelines, allows for an increased capacity for technical
services, such as histology, immunohistochemistry, molecular pathology, laser capture microscopy and
DNA/RNA extraction. BPTP SRF has increased its consent capacity through the cross training of all BPTP
SRF staff, as well as by using a universal opt-in consent for repository collections. BPTP SRF's name change
reflects its increased focus on translational pathology, facilitated by the support of faculty in the University of
Kentucky (UK) Department of Pathology who assist BPTP SRF staff in the development and interpretation of
novel assays, on-site evaluation of specimen content and quality for fresh tissue dispense and identification of
retrospective study and tissue microarray cohorts from surgical archive specimens dating back to 1995. This
partnership, strengthened by BPTP's leadership—C. Darrell Jennings, MD, chair of the Department of
Pathology and Laboratory Medicine, with Associate Director Qiuying Shi, MD, Assistant Professor in
Pathology—ensures MCC investigators have a clear path to the specimen resources and pathologic services
essential to their work. The BPTP SRF has streamlined operations by transitioning to the OnCore database
and adding a manager to oversee daily operations, leveraging existing resources within the MCC, including the
Clinical Research Office, the Surveillance, Epidemiology and End Results Kentucky Cancer Registry and
Cancer Research Informatics and Biostatistics and Bioinformatics SRFs, as well as non-MCC entities, such as
the Department of Pathology and Laboratory Medicine, UK Office of Research Integrity and the Center for
Clinical and Translational Science.